Using technology-assisted stepped-care interventions to improve adherence in adolescents with asthma

PROJECT SUMMARY/ABSTRACT
Candidate: I am a practicing pediatric psychologist whose overarching career goal is to improve health
outcomes for adolescents with asthma by targeting adherence through technology-assisted interventions. I am
an Assistant Professor of Pediatrics in the Division of Behavioral Medicine and Clinical Psychology (BMCP) at
Cincinnati Children's Hospital Medical Center (CCHMC). I completed my doctoral training at Oklahoma State
University and a T32 fellowship in pediatric adherence at CCHMC. Training Objectives: The proposed K23
will allow me to fill my current training gaps and enable me to: 1) Obtain advanced training in dissemination
and implementation science, 2) Develop knowledge of clinical care models of asthma for adolescents with a
specific focus on community health, 3) Obtain advanced training in clinical research design and biostatistics,
and 4) Enhance my professional development through grant writing skills and publications of research findings.
Mentors: My primary mentor, Kevin Hommel, PhD, is a NIH-funded researcher with expertise in clinical
research design and technology-enabled behavioral adherence-promotion interventions for adolescents. Under
Dr. Hommel's mentorship, I have assembled an expert team of leaders in asthma and pulmonary care (Drs.
Guilbert, Kahn), dissemination and implementation science (Dr. Epstein), and Statistics (Dr. Peugh) who
complement Dr. Hommel's expertise and will provide valuable mentorship. Environment: CCHMC and the
University of Cincinnati (UC) are uniquely equipped to facilitate the career development of junior researchers.
Through UC's Clinical and Translational Science Award and the Asthma Center, I have local resources to
achieve my training objectives and complete the proposed research. The Asthma Center within the Division of
Pulmonary Medicine provides access to a large patient population and I will capitalize on my existing
relationships with Asthma Center faculty. Research: My proposed research will test the preliminary efficacy of
a technology-assisted stepped-care (TASC) adherence-promotion intervention for 12-18 year old adolescents
with asthma in a pilot RCT. TASC was developed using dissemination and implementation strategies to
facilitate translation to practice and has the potential to address the limitations of available adherence
interventions for adolescents with asthma by overcoming barriers to access, providing individualized care, and
expanding the reach and impact of adherence intervention to improve the health of adolescents with asthma.
Preliminary efficacy will be demonstrated by improved adherence to daily inhaled corticosteroids as measured
by electronic monitoring devices compared to a treatment as usual (TAU) control group. Secondary outcomes
include disease severity as measured by the Composite Asthma Severity Index combining symptoms,
treatment, and exacerbations compared to TAU and an assessment of TASC implementation through a
process evaluation assessing reach, usability, and sustainability. This research will provide the basis for a fully
powered RCT to be proposed in an R01 grant application prior to the end of this K award.

Public health relevance
NARRATIVE Despite effective medical treatment for asthma and efficacious behavioral interventions to promote adherence, nonadherence remains a significant problem for up to 70% of adolescents leading to uncontrolled asthma, treatment failure, and morbidity. The proposed career development plan and research will provide the PI with the necessary training in asthma, dissemination and implementation, and clinical trials to conduct a pilot RCT of an innovative technology-assisted stepped-care (TASC) adherence-promotion intervention that can be easily disseminated. This intervention has the potential to significantly improve the health and quality of life of adolescents with asthma.